Targeting HMGA1 Tumor-Stromal Networks in Pancreatic Carcinogenesis

HMGA1 Chromatin Regulators in Pancreatic Carcinogenesis
ABSTRACT
Background: We propose to elucidate mechanisms mediated by High Mobility Group A1 (HMGA1)
chromatin regulators in pancreatic carcinogenesis. Pancreatic ductal adenocarcinomas (PDAC) are highly
lethal cancers characterized by invasive tumor cells and a dense desmoplastic stroma. HMGA1 gene expression
is activated during embryogenesis, but silenced postnatally in most adult, differentiated tissues. In diverse,
cancers, such as PDAC, HMGA1 becomes re-expressed where high levels portend adverse outcomes. HMGA1
the role of HMGA1 in pancreatic carcinogenesis is only beginning to emerge. Here, we focus on actionable
pathways downstream of HMGA1 as novel therapeutic targets in PDAC.
Our scientific premise that HMGA1 drives tumor progression in PDAC is based on the following preliminary
results: 1) HMGA1 is highly overexpressed in PDAC where high levels predict decreased survival, 2) As we
recently published (JCI, 2023), silencing HMGA1 blocks diverse oncogenic properties in PDAC cell lines while
depleting tumor-initiator cells in xenografts, 3) In KPC mice with PDAC driven by mutant Kras and Tp53,
deficiency of HMGA1 disrupts tumorigenesis while prolonging survival. 4) Surprisingly, loss of just a single
Hmga1 allele within the pancreatic epithelium is sufficient to impair both tumor and stroma formation in KPC
mice, 5) Mechanistically, HMGA1 functions as an epigenetic switch by activating transcriptional networks
involved in proliferation and oncogenic transformation in PDAC cell line models, including the FGF19 growth
factor gene, 6) Targeting FGF19 gene expression or function by FGFR4 receptor blockade in xenograft models
disrupts tumor and stroma formation, 7) Most importantly, tumors with high expression of both HMGA1 and
FGF19 define a molecular subclass of human PDAC with exceptionally poor outcomes. 8) In KPC mice, Hmga1
deficiency within pancreatic epithelium results in increasing immune cell infiltration in pancreatic tumors,
suggesting that HMGA1 also drives immune evasion by
Together, these intriguing results support the following hypotheses: 1) HMGA1 is required for PDAC
progression and stroma formation through epigenetic alterations and gene networks that foster aberrant
proliferation, differentiation, and TME signaling. 2) HMGA1 within tumor cells modulates the TME to promote
immune evasion, 3) Targeting pathways governed by HMGA1 will provide novel therapeutic strategies.
Aims/Approach: To test this, we propose the following Specific Aims: 1) To precisely define HMGA1-
dependent mechanisms in tumor progression using KPC mice and primary human tumors, and, 2) To test
targeting HMGA1 pathways for therapeutic efficacy in preclinical models.
Impact: This work should reveal new paradigms for PDAC pathogenesis and lead to novel approaches
to treat, or even prevent, these profoundly recalcitrant tumors.

Public health relevance
NARRATIVE Pancreatic cancer has emerged as a major public health problem, and unfortunately, the incidence is rising. Most patients present with advanced tumors, and even those with small, surgically removable tumors ultimately succumb to pancreatic cancer, suggesting that pancreatic tumors spread (or metastasize) even before diagnosis in most people. Thus, new treatments are urgently needed and we propose the following studies to address this important unmet need: 1) To determine why pancreatic tumors behave aggressively and spread to distant sites, and, 2) To develop novel therapeutic approaches to treat, or even prevent, these highly lethal tumors.